Mayo Clinic Breast Cancer SPORE

Program Summary/Abstract
This third renewal application of the Mayo Clinic Breast Cancer SPORE is being submitted with the vision
that the burden of breast cancer (BC) can be reduced through the performance of innovative translational
research addressing issues of high significance for women. The science of the SPORE includes three
translational research projects. Project 1: “The influence of variants in ER-positive BC predisposition genes on
BC risk and response to therapy”. This project builds upon the work from the prior funding period, where the
principal investigators (PIs) identified that certain BC predisposition genes (ATM, CHEK2 and PALB2) were
associated mainly with the risk of ER+ BC. The Pis will assess pathogenic variants in ATM, BRCA2, CHEK2,
PALB2 and determine a) age-related risks, the risks of contralateral BC and second cancers (ovarian,
colorectal, pancreatic etc.), b) the prognostic effects of these PV and c) the clinical relevance of variants of
uncertain significance in ATM, CHEK2, and PALB2. Project 2: “Improving the endocrine management of
premenopausal ER+/HER2- BC” brings forward a new ER-targeting drug, Z-endoxifen (ENDX), for
premenopausal ER+ BC based on new data that ENDX dually targets both ERα and PKCβ1, with potent
protein downregulation of ERα, Cyclin D1, and E2F1. This dual targeting is not only unique to ENDX, but at
the dosing proposed in the clinical trial, ENDX is able to completely block the stimulatory effects of
premenopausal levels of estrogen. Project 3: “Development of a novel multi-antigen BC prevention vaccine
for women with premalignant disease” is based on pioneering work of Mayo investigators to develop a novel
vaccine that targets six antigens collectively expressed by all BC subtypes. The work in this project will provide
critical information that will allow the investigators to a) understand the expression of target antigens during
progression from normal breast tissue to BC; and, b) in the phase I study, evaluate blood and breast tissue
biomarkers of immune response. Successful completion of this project will establish the parameters for a phase III
clinical trial of the vaccine for BC prevention in women with benign breast disease (BBD), with the enormous
potential to drive significant reductions in overall BC incidence and mortality. These research projects are
supported by three highly interactive cores: Core A: Administrative Core, Core B: Biospecimen and Pathology
Core, and Core C: Biostatistics, Bioinformatics, and Patient Registry Core. A Developmental Research
Program will continue to identify and develop research projects that hold the greatest promise to advance to
full SPORE projects, and a Career Enhancement Program will continue to identify and support faculty
investigators in BC translational research that have the greatest potential to become future SPORE leaders.
The investigators, cores, and the research programs in the SPORE are all integrated in the Mayo Clinic Cancer
Center. Collectively, our SPORE will make discoveries and translate them into the clinic for the benefit of
women with, or at risk of BC.

Public health relevance
Narrative The Mayo Clinic Breast Cancer SPORE addresses significant problems relating to breast cancer with the goal of reducing morbidity and mortality from the disease. This will be accomplished through projects focusing on breast cancer risk, prevention, and development of a novel approach to treat premenopausal ER+/HER2- breast cancer. The proposed research addresses vitally important issues to an enormous number of women both with, and at risk of, developing breast cancer.